Administrative supplement to investigate the role of olivocochlear efferents and hearing dysfunction in Alzheimers disease

Summary A relationship between dementia, including Alzheimer's disease (AD) has been well documented; however, the causality of this relationship and the underlying mechanisms remain uncertain. Our long-term goal is to leverage transgenic mouse models of AD to investigate this relationship, with particular attention paid to the interplay afferent and efferent auditory pathways in the cochlea and brainstem. We hypothesize that diminished cholinergic efferents in AD mutants contribute to accelerated hearing loss, peripheral damage, and suprathreshold hearing dysfunction. We propose to begin work toward our goal with one Specific Aim: Characterize peripheral and central hearing dysfunction related to efferent dysfunction and anatomical correlates in mouse models of AD. Techniques utilized in the parent grant will be applied to two mutant models of human AD neuropathology to lay the framework for future investigations elucidating the role of auditory system pathology in the progression of AD.

Public health relevance
Project Narrative: This research investigates the role of neurons that project from the brainstem to the ear in age-related hearing deficits. These neurons control the sensory activity in the inner ear and normally protect against hearing deficits and enhance hearing. It is important to understand how these neurons contribute to age-related hearing dysfunction so that we can manipulate these processes to improve hearing in older adults.